From visual snapshots to allocentric representation of a 3D world

PROJECT SUMMARY/ABSTRACT
Spatial neuroscience has uncovered a great deal about how animals—primarily rodents—form allocentric
(world-centered) spatial maps of the world. Rodents explore by moving their bodies through the world. In
contrast, primates explore the world visually, and recent work suggests this could dramatically impact their
formation of allocentric maps. The current project investigates the brain systems that allow humans to form
allocentric maps of 3D spaces from afar, without physically visiting the locations being represented. This work
will use fMRI to detect map-like representations of viewed locations in a 3-dimensional “scene space” and to
compare these to map-like representations of visited locations in a virtual “navigable space”. This work is
divided into 2 aims, the first optimized for experimental power and the second optimized for ecological
validity. Aim 1 is to identify map-like representations of scene space and understand their
relationship to cognitive maps of navigable space. Representational similarity analysis (RSA) will be
used to quantify map-like allocentric representations of locations in scene space. Experiment 1a will identify
brain regions that support viewpoint-independent (allocentric) maps of viewed locations in scene space.
Experiment 1b will use an analogous procedure to identify brain regions that support viewpoint-independent
maps of navigable space and relate them to viewpoint-independent maps of scene space. Aim 2 is to identify
representations of scene space and navigable space using dynamic, ecologically relevant tasks.
This aim will leverage voxelwise encoding models to detect map-like neural representations of viewed and
visited locations while participants actively explore their environments. Experiment 2a will look for maps of
scene-space by scanning participants while they view the virtual courtyard from different viewpoints and
actively searching for a hidden target item. Experiment 2b will look for maps of navigable space by scanning
participants while they freely navigate through the virtual environment searching for hidden rewards. This
research will take place in the ideal training environment for the applicant. The sponsorship team's expertise in
the field of spatial navigation, advanced fMRI analysis and designs, and the computational modeling of freely-
navigating participants data are critical to the applicant's training goals. Further training is available through
coursework in machine learning and data science, computing resources, and a diverse set of relevant lab
meetings and seminars. This work addresses a critical gap in the literature between the fields of vision science
and spatial neuroscience. Understanding the role of the visual system in forming spatial maps in sighted
individuals could inform interventions aimed at mitigating navigational and other challenges faced by those
with low vision or other differences in sensory processing.

Public health relevance
PROJECT NARRATIVE This proposal investigates the role of visual exploration in forming map-like representations of our surroundings. The knowledge gained from this research will be important for developing rehabilitation strategies, assistive devices, and accommodations for those with impaired sight or differences in sensory processing (e.g., from autism and ADHD), who often suffer from navigational difficulties. Moreover, because the brain regions that we plan to study are often impacted by normal aging, stroke, and neurodegenerative diseases such as Alzheimer's disease, knowledge about the role of visuo-spatial processes in these regions will be useful for predicting, diagnosing, understanding, and treating these conditions.